Measuring Neuroplastic Effects of Oscillation-Locked Transcranial Magnetic Stimulation

PROJECT SUMMARY/ABSTRACT
Major depressive disorder (MDD) is an epidemic, evident from its substantial global prevalence and burden,
and is driving other major public health issues, including economic consequences. More than 30% of
individuals living with MDD demonstrate no response to two or more antidepressant interventions and
ultimately exhibit treatment resistance. Transcranial magnetic stimulation (TMS) has emerged as a safe,
evidence-based, and non-invasive neuromodulation therapy for treatment-resistant depression. TMS utilizes
electromagnetic induction to create an electric current in the brain, depolarizing cortical neurons and eliciting
neurophysiological and behavioral effects. TMS works by inducing neuroplasticity, both within the stimulated
cortex and its broader connected networks. However, the current efficacy rate of TMS for MDD remains up to
60%. This variability in treatment response may partially result from current clinical TMS approaches failing to
incorporate the influence of brain dynamics at the time of stimulation on the neuroplastic effects and
therapeutic outcomes. In line with this notion, it may be possible to reliably improve TMS response by
enhancing the TMS-induced neuroplasticity through synchronizing the stimulation with ongoing neural activity.
An oscillation-locked stimulation protocol delivers stimulation timed to a certain phase of an endogenous
neural oscillation, which has been shown to modulate the ongoing brain activity in a more selective manner.
Specifically, oscillation-locked stimulation can reliably produce opposing neuroplastic outcomes of potentiation
or depression, depending on whether a pulse occurs at a negative-going or positive-going phase of a local
oscillatory potential. Initial investigations and my Preliminary Data indicate that this effect is present in the
human left dorsolateral prefrontal cortex, a critical hub in circuits governing cognitive and affective functions
and the most common clinical TMS target. However, these findings have not been extensively examined, and
the impact of oscillation-locked TMS on neuroplasticity has not been fully delineated. I will aim to bridge this
knowledge gap by elucidating how precise, oscillation-locked TMS induces local and network neuroplasticity
and by examining how these effects vary across the spectrum of depressive severity. My central hypothesis is
that the phase of the ongoing oscillatory activity at the time of stimulation will differentially modulate both local
(Aim 1) and network (Aim 2) neuroplasticity in adults without psychiatric diagnoses and those with MDD. This
study will advance our theoretical understanding of clinically relevant neuroplasticity and investigate the
potential of developing a brain state-dependent TMS protocol to effectively modulate relevant brain networks.
In addition to completing the proposed research study under the Kirschstein-NRSA Fellowship, I will pursue
rigorous clinical and career development activities to fulfill the requirements for my MD and PhD degrees and
establish myself as an independent physician-scientist with expertise in neuromodulation.

Public health relevance
PROJECT NARRATIVE Transcranial magnetic stimulation (TMS) is a non-invasive neuromodulation therapy for treatment-resistant neuropsychiatric disorders, but its current fixed-pattern protocols are only moderately effective, partly because they fail to account for the influence of ongoing brain dynamics on TMS outcomes. This proposal will (1) elucidate how a precise TMS application linking the stimulation to ongoing neural activity induces local and network neuroplasticity, (2) characterize the time course of these neuroplastic changes, and (3) investigate how these effects vary across the spectrum of depressive severity. This study will lay the foundational neurophysiological groundwork that may improve the treatment of major depressive disorder and other neuropsychiatric conditions.